In situ and digital spatial profiling of the active HIV reservoir in autopsy-derived tissues

Project Summary/Abstract (Project 2)
The study of HIV rebound potential necessitates rigorous viral and immunological characterization directly within
tissues in people with HIV (PWH) on ART with minimal comorbidities. As a result, this project leverages the
longitudinal San Francisco POstmortemSystematic InvesTigation of Sudden Cardiac Death (POST SCD) Study,
a postmortem study to bank samples and autopsy data on PWH and uninfected controls who were victims of
sudden cardiac death (SCD). To date we have collected extensive tissue samples, including brain, multiple
lymph node chains, liver, spleen, heart, pulmonary vasculature and other tissues of interest from47 HIV-infected
and >500 uninfected individuals who experienced SCD. Importantly, ~80% of HIV+ SCD cases were on ART
and died suddenly of non-HIV (i.e. cardiac) causes. As a result, the HIV POST SCD cohort is a one-of-kind
resource for the study of tissue HIV persistence. This highly innovative project involves in situ hybridization and
cutting-edge tissue-based transcriptomic/proteomic nanoString Digital Spatial Profiling (DSP) to clearly define
how the reservoirs of intact and HIV-expressing proviruses and biomarker expression differ between tissues and
determine how tissue-specific differences in the transcriptionally active HIV reservoir relate to in situ host cell
gene and protein expression. Our central hypothesis is that infected CD4 T cells and various myeloid lineage
cells within immune privileged histologic environments express full-length, intact HIV RNA transcripts and be
capable of rapid viral recrudescence following ART withdrawal. We expect to observe lower expression of host
antiviral factors and higher expression of pro-survival factors in cell clusters expressing HIV transcripts.
Furthermore, we posit that transcriptional activity and immune states of reservoir cells that are identified as
predictors of viral rebound in Project 3 will be visualized within specific lymphoid tissue regions of interest.
Our aims are to: 1) measure the total burden of intact and defective proviruses and HIV transcripts across the
full spectrum of different organs and tissues in vivo; 2) compare across tissues the cellular burden and
phenotypes of cells that spontaneously transcribe HIV transcripts in SCD victims on and off ART at the time of
death; and 3) determine the in situ impact of HIV burden and residual transcriptional activity on host cell factors
(particularly antiviral restriction and innate immune pathways) in tissue-resident lymphoid and myeloid cells in
SCD victims on ART compared to uninfected controls. As a result, this project will have the capacity to identify
targets for therapeutic approaches to achieve HIV cure in synergy with Projects 1 & 3.